Small Area Estimation for Cancer Risk Factors and Screening Behaviors by Combining NHIS and BRFSS for years 2017 to 2019

Collaborating with staff at the National Center for Health Statistics (NCHS) and the Centers for Disease Control and Prevention (CDC), the National Cancer Institute (NCI) has been continuing leading the efforts on producing up-to-date small area estimates for outcomes on cancer risk factors and screening behaviors using data from the National Health Interview Survey (NHIS) and the Behavioral Risk Factor Surveillance System (BRFSS) through small area modeling approach. In the past, NCHS staff has been providing programming support. For the 2017-2019 data cycle, NCI and Information Management Sciences contractor staff will run all the necessary programs through the NCHS Research Data Center (RDC) to access to the confidential county identifier information.